Profiling cell type-specific ubiquitome in UBE3A mutant mice

Project Summary
Title: Profiling cell type-specific ubiquitome in UBE3A mutant mice
Angelman Syndrome (AS) is a rare genetic and severe neurodevelopmental disorder with complex symptoms.
It is caused by the failure to inherit a typical maternal allele of the UBE3A gene, which encodes a HECT-type
ubiquitin protein ligase. This genetic mutation contributes to 85%–90% of AS cases. While UBE3A expression
and function suggest that UBE3A may target different proteins in various cell types, at different ages, and in
different brain regions, the detailed molecular mechanisms regulated by UBE3A ubiquitination in the brain remain
elusive. No study has yet identified UBE3A substrates in a cell-type and age-specific manner, nor is it known
whether UBE3A substrates are differentially ubiquitinated in different brain regions in mammalian animals due
to the lack of available tools. Identifying cell-type and age-specific UBE3A substrates is critical for understanding
the functions of UBE3A and the mechanisms underlying UBE3A deficiency in AS. This knowledge is essential
for developing potential cures for AS.
We hypothesize that UBE3A targets distinct proteins in a cell type-specific and developmental stage specific
manner in the brain. The goal of this project is to systematically identify differentially ubiquitinated proteins,
potentially UBE3A substrates, in UBE3A model mice in different cell types (excitatory and inhibitory neurons) at
different developmental stages. Additionally, we aim to investigate the spatial ubiquitination of UBE3A substrates
by visualizing their ubiquitination patterns.
We have successfully engineered a Cre-dependent Ubiquitin Tagging (CUT) mouse line designed to selectively
tag endogenously ubiquitinated proteins within specific cell types in the mouse tissue. This innovative mouse
line facilitates spatial visualization of protein ubiquitination within specific cell types at the single-cell level and
enables purification of ubiquitinated proteins in specific cell types for cell-type-specific ubiquitome profiling. By
combining our specific-Cre::CUT tool with Proximity Ligation Assay (PLA) and confocal microscopy, we will
visualize cell type-specific and age-specific ubiquitination of UBE3A substrates at the single-cell level in different
brain regions. Focusing on the P7 and P56 cortical brain regions, we will generate triple transgenic mice (Nex1-
cre::CUT::Ube3am-/p+ for excitatory neurons and Gad2-cre::CUT::Ube3am-/p+ for inhibitory neurons) to profile
ubiquitomes using pulldown experiments and mass spectrometry. This will help identify differentially ubiquitinated
proteins and potential UBE3A targets across different cell types and ages, allowing for a comprehensive analysis
of UBE3A functions.
This study will identify differentially ubiquitinated proteins in UBE3A mutant mice in both excitatory and inhibitory
neurons at different ages. This will elucidate UBE3A's varying functions across cell types and ages, enhancing
our understanding of its role in AS and advancing towards effective treatments. Our data will also serve as a
valuable resource for AS research.

Public health relevance
Project Narrative This research seeks to elucidate the intricate mechanisms underlying Angelman Syndrome (AS) caused by UBE3A deficiency. By identifying UBE3A substrates across specific cell types, ages, and spatial contexts, it aims to shed light on the multifaceted functions of UBE3A, thereby further our understanding of AS pathology and paving the way for targeted therapeutic interventions. Furthermore, the insights gained from this study will be a valuable resource for the broader AS research community, aiding ongoing efforts to address this complex neurological disorder.